University of California and UT Southwestern D-PDTC

PROJECT SUMMARY/ABSTRACT
The University of California and the University of Texas Southwestern (UCaTS) Diversity Patient-Derived
Xenograft (PDX) Development and Trial Center’s is a diversity-focused grant with a goal of establishing and
characterizing at least 120 new PDXs from racially and ethnically diverse populations and use these PDXs as
preclinical models to better understand the mechanisms of oncogenesis, to test FDA-approved and NCI-CTEP
single agent and drug combination therapies and to advance cancer health disparities research. Expanding the
existing PDX infrastructure from our ongoing University of California Patient Derived and Trial Center (UCaMP,
U54CA233306), UCaTS is comprised of six NCI-designated Comprehensive Cancer Centers (CCC): UC Davis
Comprehensive Cancer Center (UCD) [lead institution], UC Irvine Chao Family Comprehensive Cancer Center
(UCI), UC Los Angeles Jonsson Comprehensive Cancer Center (UCLA), UC San Diego Moores Cancer Center
(UCSD), UC San Francisco Helen Diller Family Comprehensive Cancer Center (UCSF), and the University of
Texas Southwestern Harold C. Simmons Cancer Center (UTSW). Collectively, UCaTS includes a team of
transdisciplinary investigators with strengths in PDX development, preclinical drug testing, cancer health
disparities, clinical trial development, bioinformatics, and large multicenter administration. UCaTS will achieve
its goal through two Research Projects. Project 1 – “Advancing gastric cancer precision medicine in Latinos
through patient-derived modeling” focuses on developing novel, effective therapeutic regimens for most
commonly druggable and genomically complex Latino GC subtype, which involves co-mutations in multiple
pathway (such as cell cycle kinase, PI3K/AKT/mTOR, WNT and RTK-RAS) and to study resistance mechanisms
to targeted therapies, identify response biomarkers and assess how ancestry influences response. Project 2 –
“Precision targeting of disparity-associated EGFR mutant lung tumors to circumvent early resistance to EGFR
inhibitors”, focuses on one of the most common lung cancer (LC) subtypes in minority populations, EGFR-
mutated lung tumors. This molecular subtype represents a high proportion of lung cancer diagnosed in female
patients of Latino and Asian ancestry. The project will utilize PDXNet and our UCaTS lung cancer PDX expertise
and resources to develop effective targeted therapy combinations with FDA-approved and NCI-CTEP agents
seeking to overcome early resistance to EGFR-TKIs.

Public health relevance
OVERALL NARRATIVE The University of California and University of Texas Southwestern Diversity Patient-Derived Xenograft Development and Trial Center takes advantage of the collective strengths of six NCI-Comprehensive Cancer Centers to create minority patient cancer models and characterize targeted treatment responses to stomach and lung tumors. The impact of this collaborative is to understand the biological processes involved in cancer health disparities and to develop new effective treatments in patient-derived models to translate into clinical trials.